Dopamine and Motor Learning in Cerebral Palsy

Data collection for Objective 2 was quite active before the COVID pandemic. During that time period, our genetics collaborator accepted a position at Johns Hopkins University and was no longer able to collaborate with us. We were able to collect data on a few more participants before the genetics lab closed, but we did not fully complete the intended enrollment.

We were able to arrange to have the data processed at an outside facility and we assigned a MSRP student to this project who completed data processing and analyses during the past year and drafted a manuscript before he left. The goal is to submit this in the next several months.